DanFreez: Zebrafish Genetically-Optimized for Cryogenic Storage of Embryos

Summary:
Unlike C. elegans and mice, methods for cold storage of zebraﬁsh lines are lacking in the marketplace. We propose the
use of environmental and gene c factors to enable cold storage of viable embryos at frozen or near freezing condi ons.
In Aim 1 we will explore the use of transient protein expression to produce proteins associated with anhydrobio c status.
In Aim 2 we explore the induc on of genes involved in diapause in killiﬁsh as a mechanism to promote cold-storage
survival. In Aim 3, we will look at combina ons of gene c and environmental factors that promote reanima on of
zebraﬁsh embryos from cold storage. Achievement of any one of these aims that result in high viability yields from cold
storage can then be developed in Phase II as a gene cally integrated line, which can then be broadly commercialized as a
product or service to aid researchers in their biobanking eﬀorts with their zebraﬁsh lines.

Public health relevance
Narra ve: The zebraﬁsh animal model is a fast-growing biomedical research tool. Yet broader u liza on of zebraﬁsh in research is hampered by an inability to achieve long-term cold storage of transgenic lines. This SBIR project funds the development of systems to enable cryopreserva on of zebraﬁsh lines.